MOLECULAR MECHANISMS OF TRANSCRIPTION TERMINATION

Rho is a protein from E. coli which binds to mRNA and causes the release of transcripts from transcription complexes at discrete sites on DNA templates. The aim of this proposal is to determine those structural features of the mRNA which are critical for specific interactions with rho, and to understand how rho couples mRNA binding, ATPase activity, and possible interactions with RNA polymerase to cause transcription termination. The general features of specific rho-dependent termination sites will be explored by rapid DNA sequencing and in vitro mutagenesis techniques. The specific nature of rho-mRNA interactions will be investigated by RNA "footprinting" and electron microscopy. Chemical crosslinking, affinity chromatographpy, and electron microscopy will be employed to determine if rho interacts specifically with other components of transcription or translation.